Effective combination therapy for MTAP-deficient bladder carcinoma by targeting metabolic vulnerability and modulating tumor immune microenvironment

PROJECT SUMMARY/ABSTRACT
The long-term goals of this project are to define the mechanisms of resistance to immunotherapy and to develop
effective therapies for patients with metastatic bladder cancer (BC). The overall objective of this proposal is to
establish successful combination therapies for patients with a specific genomic subset of metastatic BC
harboring homozygous deletion of the methylthioadenosine phosphorylase (MTAP) gene from the chromosome
9p21 region. Although novel immune checkpoint therapy (ICT), including anti-PD1/PD-L1, provides substantial
benefits to patients with metastatic BC, response rates are usually modest at 15% to 25%. This is partly because
this biologically heterogeneous cancer is still treated clinically as a uniform disease. Therefore, identification of
specific genomic subtypes of BC that confer insensitivity to ICT may provide novel opportunities to improve
clinical responses. We have confirmed that ~1/4 of BC contain homozygous deletion of MTAP (MTAPdef) from
the 9p21region. The MTAP gene encodes for an essential enzyme to catalyze methylthioadenosine (MTA) in
the salvage pathway for adenine synthesis. Tumor MTAPdef leads to both immunologic and metabolic
consequences. Immunologically, tumor MTAPdef results in accumulation of its substrate MTA, which acts through
the adenosine 2B receptor (A2BR) to inhibit IFN signaling and T cell function. Therefore, MTAPdef BC may foster
a “cold” tumor immune microenvironment (TIME) unfavorable to ICT. Metabolically, tumor MTAPdef results in a
lack of salvage pathway adenine synthesis; thus, MTAPdef BC should be very sensitive to the cytotoxic effects of
anti-folate agents (e.g., pemetrexed), which effectively inhibit de novo adenine synthesis. This concept is
confirmed by pre-clinical and clinical data to be presented. Importantly, our data also indicate that pemetrexed
increases tumor immune cell infiltration and PD-L1 expression and thus may sensitize BC to ICT. Based on
these data, we hypothesize that, by targeting the metabolic vulnerability of MTAPdef BC and directly modulating
its tumor immune microenvironment, effective combination therapies can be established for MTAPdef BC. To test
this hypothesis, we proposed two Specific Aims: (1) Define the immunological consequences of MTAPdef in BC;
(2) Identify successful combination therapies specifically targeting MTAPdef BC. Patient-derived BC tissues, gene
knockout and “rescue” mouse BC models, and samples from an IRB-approved clinical trial will be used to
address these goals. At completion, we expect to establish the contribution of MTAPdef and/or loss of adjacent
genes such as CDKN2A in the 9p21 region to the BC TIME. In addition, we will determine the extent of TIME
modulation by pemetrexed +/- avelumab (anti-PD-L1) in relation to their therapeutic efficacy in patients with
metastatic BC. Furthermore, we will define the preclinical therapeutic benefits of triple combination treatment
with pemetrexed, anti-PD-L1, and A2RB inhibitor on mouse MTAPdef BC. These findings are important for the
establishment of novel, biomarker-guided, highly effective combination therapies that can be tested in clinical
trials. These data could be extrapolated to 14% of all cancers containing MTAPdef in the 9p21 region.

Public health relevance
PROJECT NARRATIVE The overall object in the proposed research is to establish a highly effective,biomarker-guided, triple combination therapy for treatment of a large subgroup of patients with a relatively common genotype, which occurs in 25% of bladder cancer. In this genotype, there is a homozygous loss of the methylthioadenosine phosphorylase (MTAP) gene in the chromosome 9p21 region, making these bladder tumors metabolically vulnerable to therapeutic modulation of the tumor immune microenvironment, which would render them sensitive to immune checkpoint therapy. These findings could potentially be extrapolated to other malignancies, as MTAP represents one of the most frequently deleted somatic genes, occurring in 14% of all human cancers.